Platform to accurately recapitulate and perturb cortical development and morphogenesis in vitro

Abstract
The application's broad objective is to recapitulate critical features of the developing human forebrain, including
its patterning, morphology, and regional cellular organization. The application also seeks to develop a robust
platform to perform high throughput penetrant and cell type-specific genetic perturbations to elucidate the
mechanisms underlying human forebrain development. In doing so, it develops and integrates novel
technologies from stem cell and developmental biology, molecular biology, bioengineering, single-cell genomics,
and imaging.
Given that model organisms inadequately mirror human brain development and disease, and ethical constraints
limit direct human brain studies, it's imperative to develop in vitro models that accurately represent its
microenvironment, organization, and function. Accurately reproducing the developing brain's attributes and the
ability to perturb the genetic network at scale is crucial to decipher mechanisms underpinning human brain
development and disease.
In preliminary work, we established bioengineering methods to print and differentiate single-lumen cysts into
forebrain-like tissue. We further demonstrated that coupling these cysts with signal coated generates spatial
gradients of signals. With the ability to expose hundreds of organoids per experiment to distinct signaling
gradients and using statistical analysis, we could rapidly learn how to generate correctly patterned complex
tissues. Using these approaches, we will generate organoids with correctly integrated choroid plexus producing
cerebrospinal fluid, an adjacent cortical hem, a more distal correctly layered cortex, and ventral inhibitory
interneuron progenitors. The cortical hem and choroid plexus, adjacent to the developing cortical tissue, are
essential for proper cortical development. We expect to be successful, given our preliminary results, and believe
that the resulting platform to study human brain development will be broadly useful to the community.
Further in preliminary work, we established bioengineering methods for targeted penetrant perturbation of
individual organoids on a coverslip at a scale that was impossible previously because of the very high costs.
This platform will allow us to perturb hundreds of genes per experiment, and we will test and demonstrate its
capabilities by identifying human-specific mechanisms of forebrain neural tube patterning and closure.
Uncovering mechanisms underlying the patterning and morphogenetic events leading to neural tube closure is
essential for understanding human brain development.
In sum, the proposal will establish a platform to mimic human brain development more accurately and further
establish the ability to perform penetrant genetic perturbations, both at a scale not previously possible. Together
these abilities will allow the community to better understand the development, morphogenesis, and mechanisms
governing human brain development and disease.

Public health relevance
Narrative The proposal aims to recapitulate key features of early human brain development using pluripotent stem cells, and methods to perturb the underlying genetic network. If successful, it will lead to robust platforms to understand early human development and diseases, and in the long term could lead to the development of therapies.